Community Engagement Core

Project Summary
Mount Sinai has a long, distinguished history of advancing research on the role of environment in health across
the life course. Through Mount Sinai's pediatric and adult environmental health clinics and our geographic
location in East Harlem, the Community Engagement Core (CEC) of the P30 Center on Health and Environment
Across the LifeSpan is uniquely poised to champion transformational change by providing resources, expertise,
and opportunities to translate environmental health science (EHS) research into meaningful action. The CEC's
mission is rooted in equitable community partnership bonded by a shared commitment to effect change for
communities disproportionately burdened by environmental exposures. To achieve our mission and advance
the overall goals of the Center, the CEC will implement specific plans over the next 5 years. (1) We will
systematically integrate community voices spanning community members, policy-makers, public health
officials, healthcare professionals, and educators into Center academic forums, to more effectively
communicate diverse community issues and concerns to Center Members and inform and guide them in
developing research activities that address community needs. The CEC will build upon the successful EHS
Accelerator model to address priority community concerns that strengthen, mobilize, and expand outcomes from
the entire Center by sharing them with our diverse set of networks, including the NIEHS P30 Center Network and
Clinical and Translational Science Award (CTSA) Network, other regions of the PEHSU, the American Academy
of Pediatrics, and more. (2) We will work together with Center Members and our community partners to
translate and disseminate Center research results into environmental public health knowledge to
increase awareness and understanding of environmental health research being conducted at the Center
and inform needed change. The CEC will offer consultations to assist in the development of translational tools.
Together with regional and national partners, we will center EHS in programs and policies across diverse sectors
(clinical, medical education, community, and policy), as outlined in the NIEHS Translational Research
Framework, to ensure that low-income, predominantly Black and LatinX communities disproportionately
burdened by environmental exposures directly benefit from the knowledge gained from Center research. Finally,
(3) we will advance the field of community engagement and environmental health communication to
promote evidence-based models for national implementation and demonstrate impact through
measurable outcomes. Toward this end, the CEC works with a continually expanding network of partners to
accelerate change, address environmental health inequities, and promote health and well-being across the
lifespan.